Harnessing biophysical cues to spatially organize developing cardiac organoids

Abstract:
Current 2D in vitro monocultures and animal models fall short in accurately modeling cardiovascular genetic
disorders, leading to inadequate therapeutic development. Recent advances have now centered on 3D organoid
models due to their improved cellular heterogeneity. However, cardiac organoids still lack crucial structural
characteristics, cell types, and cellular organization which limits their utility. While recent approaches focus on
modifying morphogens, none have used mechanical cues as guides for the differentiation process. Preliminary
data presented within reveal that microconfining stem cell colonies on compliant substrates facilitates cardiac
organoid generation and release, with substrate stiffness and geometric asymmetry influencing the spatial
organization of organoid structure. The research proposed in this fellowship will explore these findings further to
develop a roadmap for engineering-in the missing structural components. By modulating matrix mechanics, we
aim to replicate developmental stiffness, guiding traction stresses and cell polarization during early differentiation
stages. Gradients and temporal changes of stiffness may push towards cardiac mesoderm specification via
presentation of a more physiologically representative mechanical environment. Controlling local cell densities
and geometric confinement may further play a role in guiding final organoid architecture and cell heterogeneity
and distribution. Overall, the goal is this work is to establish a platform that can reproducibly create cardiac
organoids with tunable spatial control for drug screening applications, with scope for application towards other
organoid types.

Public health relevance
Project narrative: This proposal seeks to use hydrogel engineering to enhance the generation of cardiac organoids from human pluripotent stem cells. This fellowship will investigate how mechanical cues can guide the generation of cardiac organoids, which can guide us to create more representative tissue models that will expediate our understanding of genetic disorders. Furthermore, having a high throughput platform of reproducible organoids will allow us to improve our drug screening and develop better treatment options for heart failure.